Meta-analysis in human brain mapping

This is the competing renewal of the R01 (MH074457-14) which sustains the BrainMap Project
(www.brainmap.org). BrainMap is a neuroimaging research resource facilitating cognitive neuroscience and
disease-biomarker discovery via coordinate-based meta-analysis (CBMA). BrainMap provides its end-user
community with: curated 3-D coordinate data and experimental metadata from peer-reviewed publications;
extensively validated computational tools for CBMA; CBMA-derived tools for data interpretation (e.g., functional
property and disease loadings by location) and data analysis (e.g., via CBMA-derived disease models);
instructional materials and on-site and on-line venues for learning CBMA methods; and, on-going end-user
support. At present, BrainMap.org hosts two coordinate-based databases: task-activation (TA DB) and voxel-
based morphometry (VBM DB). A voxel-based physiology database (VBP DB) is in the planning and piloting
phase. BrainMap maintains an integrated pipeline of cross-platform (Java) tools for data coding (Scribe),
filtered retrieval (Sleuth), activation-likelihood estimation (ALE) CBMA (GingerALE), data visualization (Mango),
and data interpretation (CBMA-derived Mango plugins). Multiple network-modeling approaches have been
successfully applied to BrainMap data – independent components analysis (ICA), author-topic modeling
(ATM), graph-theory modeling (GTM), structural equation modeling (SEM), connectivity-based parcellation
(CBP), and meta-analytic connectivity modeling (MACM) – but none are yet optimized and “pipelined” for
general use. Utilization of BrainMap resources is substantial: our software, data and meta-data have been
used in >1,000 peer-reviewed articles. Of these, > 500 were published in the current funding cycle (2015-
2020). Four aims are proposed, to maintain and extend this high-impact research resource.
Aim 1. Voxel-based Physiology DataBase (VBP DB) with Analysis Exemplars.
Aim 2. BrainMap Community Portal for Multivariate Modeling with Applications & Exemplars.
Aim 3. Large-scale Parameter Estimations.
Aim 4. BrainMap Pipeline Enhancements and Community Support.

Public health relevance
The overall goal of the BrainMap Project is to provide the human neuroimaging community with curated data sets, metadata, computational tools, and related resources that enable coordinate-based meta-analyses (CBMA), meta-analytic connectivity modeling (MACM), meta-data informed interpretation (“decoding”) of imaging results, and meta-analytic priors for mining (including machine learning) primary (per-subject) neuroimaging data.